REPRODUCIBLITY OF SURFACE VERSUS INTRAMUSCULAR GENIOGLOSSUS ELECTROMYOGRAPH

To determine the accuracy of muscle signal collected using the two methods. Also to determine the reproducibility of muscle signals collected using the two method.